ROLE OF CEREBRAL HEMODYNAMICS IN ISCHEMIC STROKE

This project will prospectively investigate the role of cerebral hemodynamic factors in the pathogenesis of stroke in patients with symptomatic and asymptomatic carotid artery occlusion using positron emission tomography (PET).